Metabolic requirements of pancreatic beta cell proliferation

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) results from autoimmune destruction of pancreatic β-cells. Potential therapeutic
approaches to curtail or reverse the loss of β-cells include immune modulation, β-cell regeneration, or
combinations thereof. There has been substantial preclinical development of therapies that stimulate human β-
cell replication. However, absolute proliferation rates induced by such drugs remain relatively low, and it is
unclear whether current approaches will sufficiently expand β-cell numbers to control blood glucose without
exogenous insulin. Here, we build upon emerging evidence that cell metabolism supports proliferation to identify
and exploit metabolic bottlenecks that limit therapeutic β-cell expansion. Proliferating cells are known to activate
metabolic programs that produce cellular building blocks and generate signals that support cell division. In
preliminary data, we found that the metabolic enzyme ATP-citrate lyase (Acly) is required for expansion of
transformed β-cells. Other groups have shown that pancreatic deletion of Acly results in smaller islets, consistent
with a role for this enzyme in β-cell proliferation. Acly acts upon citrate to produce acetyl-CoA, which is a
substrate for lipid synthesis and histone acetylation. In this way, Acly couples mitochondrial metabolism to
production of cellular building blocks and signaling via the epigenome. In β-cells, Acly deletion results in
downregulation of lipid synthesis genes concomitant with reduced histone acetylation of their associated
regulatory elements, suggesting Acly regulates lipid synthesis through dual metabolic and epigenetic
mechanisms. Together, these observations build the model that Acly produces both anabolic and signaling
metabolites that support β-cell proliferation. We found that Acly is phosphorylated by mitogenic signals,
suggesting it could be activated during β-cell proliferation to drive requisite changes in metabolism. Our central
hypothesis is that mitogens remodel β-cell lipid metabolism through Acly, and that this effect is necessary for
optimal β-cell proliferation. Here, we will test how changes to islet lipid metabolism support β-cell proliferation in
primary human islets using genetic or metabolic interventions coupled with targeted metabolomics and genomic
assays. In Aim 1, we will monitor the effect of pro-proliferative drugs on islet lipid synthesis and test whether
metabolites affected by mitogenic signals limit β-cell proliferation. To assess the requirement for lipid synthesis
pathways downstream of Acly, we will determine how ACLY inactivation impacts human β-cell proliferation under
the same conditions. In Aim 2, we will assess how the islet epigenome is remodeled in response to β-cell
mitogens. Islets will be treated with pro-proliferative drug combinations, then we will perform ChIP-seq for histone
modifications previously implicated in governing β-cell proliferation. We will also determine the epigenetic
signaling function of Acly by testing its role in nutrient-stimulated histone acetylation in human islets.
Understanding the metabolic pathways that support or augment pharmacological β-cell expansion could inform
nutritional interventions to optimize β-cell regeneration by therapies currently in preclinical development.

Public health relevance
PROJECT NARRATIVE People with type 1 diabetes suffer chronic complications and are at risk of life-threatening episodes of hypoglycemia and diabetic ketoacidosis. Therapies that increase the number of residual β-cells have been proposed as a strategy to delay or reverse insulin dependence in people with prediabetes or in the “honeymoon” phase of the disease. This research will address whether changes to β-cell metabolism impact the effectiveness of such therapies, opening the possibility for combined drug and dietary interventions to prevent or reverse disease progression.